Improving Measurement and Documentation of Long-term Neighborhood Change and Racial Segregation

PROJECT SUMMARY/ABSTRACT
This is a study of neighborhood racial change and its impacts on trends in Black-white segregation over a
multi-decade time span. It will provide much new information about settlement patterns that continue to
impact residents' health, social class mobility, and quality of daily life. It will trace changes in population
composition at the neighborhood scale within constant geographic boundaries, and evaluate how different
patterns of neighborhood change contributed to increasing or declining segregation in the larger urban area. It
will compare the period 1930-1950, when white flight and minority “invasion and succession” were creating
more racially homogeneous neighborhoods and magnifying segregation in cities to two later phases. These are
1950-1980, when segregation within cities began to give way to the new divide between cities and suburbs, and
after 1980 when segregation declined in cities while remaining more persistent in suburbia.
An important contribution of this project is to develop a neighborhood-scale data base with consistent
boundaries over time for multiple decades to support the proposed analyses. It will use methods developed for
the Longitudinal Tract Data Base (LTDB) for 1970-2020 and the Urban Transition HGIS Project (1880-1940).
A major effort will be to incorporate data and map sources that are now becoming available. The project will
develop harmonized neighborhood data for 69 major cities for 1930-1950 and for them plus their surrounding
suburbs for 1950-2020, making possible detailed studies of suburban development after World War II.

Public health relevance
PROJECT NARRATIVE This study tracks the trajectories of neighborhood change segregating Blacks from whites for a large sample of cities and metropolitan areas from the early 20th Century through 2020. It will compare changes that were dominated by white flight and minority invasion/succession in the 1930s and 1940s to the postwar period when segregation stemmed increasingly from the exclusion of Blacks from fast-growing suburbs, and recent decades when segregation has begun to decline. The harmonized neighborhood data base developed for this analysis will be made publicly available, supporting a much wider range of studies of urban change.